High affinity IgG Fc receptor FcγRIA variants as novel genetic markers for sarcoidosis

PROJECT SUMMARY Sarcoidosis is a multisystem granulomatous disorder of unknown etiology. Sarcoidosis frequently affects the lungs and may cause significant morbidity and mortality. Environmental factors are considered as potential triggers for the disease, but no single trigger for the development of sarcoidosis has been identified. The critical role for genetic factors contributing to sarcoidosis etiology is strongly supported by twin studies, disease clustering in families, and racial differences in incidence rates. Multiple genes may be involved in sarcoidosis, but no gene has been functionally demonstrated to influence sarcoidosis. Up to now, biomarkers for sarcoidosis have not been identified. Clinically, the elevated IgG and IgG immune complexes in the circulation and the changed expressions of low affinity IgG Fc receptors (FcγRs) on immune cells were found in sarcoidosis patients, suggesting that IgG production and FcγRs may be involved in the pathogenesis of sarcoidosis. As the sole high affinity FcγR capable of binding monomeric IgG, FcγRIA contributes substantially to inflammatory and immune responses. FcγRIA has eluded the genetic analysis thus far due to the existence of other highly homologous genes in human genome. In the preliminary studies, we have developed genotyping assays and identified two novel single nucleotide polymorphisms (SNPs) within FcγRIA gene. Our preliminary data also show that the expressions of FcγRIA on monocytes and neutrophils were significantly increased in sarcoidosis patients compared to healthy controls and that FcγRIA SNPs were associated with sarcoidosis susceptibility and severity. Our data indicate that FcγRIA genetic variations may have a significant impact on the development of sarcoidosis. The genetic effects of FcγRIA on sarcoidosis and other inflammatory diseases are unknown to date. Therefore, we hypothesize that FcγRIA genetic variations affect receptor functions and influence the pathogenesis of sarcoidosis. We will vigorously test our hypothesis through the following specific aims: 1) to identify novel SNPs in FcγRIA gene and to determine whether FcγRIA SNPs are risk factors for sarcoidosis and disease severity; and 2) to determine to determine whether FcγRIA variants affect receptor functions. The delineation of the role of FcγRIA variants in the development of sarcoidosis will provide significant insights into the genetics of sarcoidosis and the immunological mechanism of sarcoidosis. Our study may also lead to new strategies for diagnosis and prognosis of sarcoidosis and other inflammatory diseases, significantly contributing to the goal of precision (or personalized) medicine.

Public health relevance
PROJECT NARRATIVE Sarcoidosis is a granulomatous disease causing significant morbidity and mortality. Genetic factors are known to contribute to the development of sarcoidosis. The present study is intended to determine whether genetic variations of the high affinity immunoglobulin Fc receptor gene influence the development of sarcoidosis.